Keratin-dependent regulation of progenitor keratinocyte identity and commitment to differentiation

Abstract
Keratins are intermediate filament (IF) forming proteins whose expression and post-translational modifications
are tightly regulated in response to development, differentiation, stress, and disease. Keratin 14 (K14) is highly
expressed in progenitor keratinocytes located in the basal layer of stratified squamous epithelia, including the
skin epidermis. K14 and its obligate assembly partner keratin 5 (K5) form highly stable coiled-coil dimers that
further polymerize into 10 nm keratin IF filaments in basal keratinocytes. The coiled-coiled structure of all IF
proteins including K5/K14 heterodimers is made possible by long-range heptad repeats located within their
defining, central rod domain. All IF proteins contain a 4-residue disruption in this heptad repeat at a specific
location within the rod domain, known as the stutter region. K14 and select keratins expressed in surface epithelia
contain an evolutionarily conserved cysteine residue in position 2 within the stuffer motif (mouse K14 C373). The
functions of the stutter region and its conserved cysteine remain incompletely defined. Recent work in the
Coulombe lab identified a role for K14 stutter cysteine in the regulation of epidermal homeostasis. Expanding
upon prior a crystal structure determination and follow-up observations, we generated a Krt14 C373A mouse
line, which shows altered K14-dependent disulfide bonding in the epidermis. The remarkable molecular
phenotype of the Krt14 C373A mouse informed our current mechanism proposing that disulfide bonded K14
binds to the scaffolding protein 14-3-3σ, in a differentiation cue-dependent fashion, leading to sequestration and
inactivation of the pro-growth transcriptional co-activator YAP1. As part of ongoing studies, we sought to
accentuate the otherwise subtle Krt14 C373A gross phenotype, in contrast to its molecular phenotype, by
generating a novel mouse line, Krt14 C373A/null. The Krt14 C373A/null mouse contains a single mutant Krt14
allele, resulting in reduced levels of K14 post-translationally modified at the stutter. The Krt14 C373A/null mouse
phenotype presents with precocious post-natal development, hair follicle abnormalities, and crowded, irregular
basal keratinocyte nuclei in the skin and tongue. From observations made so far using Krt14 C373A/null mice I
hypothesize that the concentration and proportion of stutter cysteine-dependent disulfide bonded K14
within the keratin IF network of basal keratinocytes define basal keratinocyte identity and regulate their
entry into terminal differentiation. Further, I hypothesize that alterations in the regulation of basal cell
identity will promote skin cancer initiation and progression. This hypothesis proposes that basal
keratinocyte identity is defined by the composition of the keratin filament network, including K14 and an additional
type I keratin, K15, and that the proper balance of K15 and disulfide-bonded K14 prevents pathological growth
of progenitor keratinocytes. Altogether the testing of these hypotheses, mechanism, and the Krt14 C373A/null
mouse model will shed critical insight into the regulation of keratinocyte differentiation and permit more effective
and targeted medicine towards the failure of homeostasis that underlies the complex pathology of skin cancer.

Public health relevance
Project Narrative The healthy functioning of the skin epithelium requires a balance of cell proliferation, differentiation and cell loss through the process of epidermal homeostasis. Previous work in the Coulombe lab discovered a signaling role for the disulfide-bonded keratin 14, an intermediate filament-forming protein, in the regulation of epidermal homeostasis. In this study I will use a novel transgenic mouse model to further define the function of the keratin intermediate filaments and relevant post-translational modifications in the regulation of epidermal homeostasis and directly test this mechanism in the pathophysiology of skin cancer.